Equipment Supplement for Centromere Interactions and Meiotic Chromosome Segregation in Yeast

Summary of parent project (R01GM138889) In prophase of meiosis I, homologous chromosomes pair and become connected by crossovers. The connection provided by crossovers helps the partners attach to microtubules that radiate from opposite sides of the spindle. This bipolar attachment is stabilized by tension as the partner kinetochores are tugged towards opposite poles by the connected microtubules. This allows the chromosome pair to remain poised at the spindle mid-zone while other pairs become correctly attached to microtubules. Our parent grant is focused on centromere-pairing. This occurs when the centromeres of the partner chromosomes come together and then become attached in a poorly understood way that, like crossovers, allows the homologous partners to correctly form bipolar attachments, even if they have failed to become attached by a crossover. We have proposed experiments in the parent project to monitor the behavior of centromeres as the chromosome partners become attached to the spindle in meiosis I. Nearly half of the experiments in the proposal involve sustained imaging of living meiotic yeast cells. We have proposed to image fluorescently-tagged centromeres, in cells that are sustained in microfluidics chambers mounted on the microscope stage. In these experiments genes of interest can be interrogated for their roles in the biorientation process by flowing over the cells compounds that trigger the expression of specific genes or the degradation of specific proteins. In addition, we propose to measure the ability of crossovers and centromere connections between homologous partner chromosomes to transmit tension between the homologous kinetochores. This will allow us to ask questions about the biophysical properties of connections that do, or do not, stabilize bioriented microtubule attachments. These experiments measure the Brownian vibration of the kinetochores as a means to determine the spring-stiffness of the connection between them (provided by a crossover or centromere connection) (Fig. 1). Together the experiments will define to0.5 s Soft Spring Stiff Spring Figure 1. Kymograph of GFP- tagged bi- oriented centromeres. \Image analysis tracks the centroid of each GFP focus and changes in distance between centroids. Image from M. Gardner. molecular basis of the bridge formed between partner centromeres by the centromere pairing process and the biophysical characteristics of connections formed by centromere pairing and crossing-over.

Public health relevance
Project Narrative Errors in the process of distributing chromosomes to the gametes is the major cause of birth defects and mental retardation and is a major contributor to infertility. This project uses budding yeast to identify undiscovered ways in which a component of the chromosome, called the centromere, might help direct chromosomes movements, in doing so, helping to prevent the errors that lead to birth defects.